Harnessing Aurora kinase inhibition‐induced cell death to enhance immunotherapy in HPV‐driven cancers

PROJECT SUMMARY
Human papillomavirus (HPV)-driven cancers are common and lethal. There are no biomarker-selected,
molecular targeted therapies for HPV+ cancers. Most of those who progress after initial therapy with radiation
and chemotherapy die within 3 years, demonstrating a significant translational knowledge gap and an unmet
clinical need. Anti-PD1 immune checkpoint therapy (ICT) is effective for recurrent HPV+ cancers, but with
response rates of <20% and a one-year survival rate of <40%. To address the unmet need for biomarker-
driven therapy for HPV+ cancers, we tested the efficacy of 721 unique drugs in 16 HPV+ and 17 matched
HPV-negative cell lines and identified Aurora kinase inhibitors as more effective in HPV+ than HPV negative
cancers. We demonstrated that Aurora kinase inhibition leads to apoptosis in HPV+ cell lines in vitro and
reduced the growth of an HPV+ HNSCC patient-derived xenograft tumor in vivo. HPV+ cancer cells may be
sensitive to Aurora inhibition because of their low Rb expression. RB1 loss and Aurora inhibition are
synthetically lethal in a variety of cancer cell lines and preclinical mouse models. Although the mechanism
underlying this synthetic lethality is unknown, the fact that multiple mitotic genes were identified in screens
suggests that Rb's roles in mitosis and genomic stability are a central part of this mechanism. HPV+ cancers
may rely on mitotic kinases such as Aurora to maintain mitotic fidelity. We hypothesize that Aurora kinase
inhibition results in cell death in HPV+ cancers due to Rb loss-induced genomic instability. Furthermore, we
hypothesize that this cancer cell death will stimulate the cGAS/STING pathway producing type I interferons
and the resulting immunogenic cell death will lead to host T-cell engagement and increased sensitivity to ICT.
This second hypothesis is crucial because cancers nearly always develop resistance to even highly effective
targeted therapies, limiting their long-term benefits. In contrast, ICT results in durable responses in some
patients, making it imperative to seek strategies that enhance the efficacy of ICT. To meet our long-term goal
of improving cure rates for those with HPV+ cancer, we propose mechanistic studies to elucidate the role of Rb
loss-induced genomic instability in Aurora kinase inhibition mediated cancer cell death (Aim 1); in vivo
experiments with the combination of Aurora kinase inhibition and ICT in HPV+ murine model (Aim 2); and to
leverage tissue from a clinical trial to dentify biomarkers predicting response to the combination of immune
checkpoint and Aurora kinase inhibition in patients with recurrent HPV+ cancers. Our proposed research will
have a positive impact because it will address an important problem, the lack of curative therapy for recurrent
HPV+ cancers, and may shift current clinical practice paradigms for these cancers by identifying rational ICT
and targeted drug combinations.

Public health relevance
PROJECT NARRATIVE There are no biomarker-selected, molecular targeted therapies for human papillomavirus (HPV) positive cancers. Aurora kinase inhibitors lead to cell death preferentially in HPV+ cancers and this death may sensitize HPV+ cancers to immunotherapy. To meet our long-term goal of improving cure rates for those with HPV+ cancer, we propose to test the hypothesis that Aurora kinase inhibition leads to cell death in HPV+ cancers due to Rb loss-induced genomic instability, to test the hypothesis that Aurora kinase inhibition will result in increased sensitivity to immune checkpoint therapy, and to identify biomarkers predicting response to the combination of immune checkpoint and Aurora kinase inhibition in patients with recurrent HPV+ cancers.